Function, caregiving and adequacy of support before and after the transition to institutional settings

PROJECT SUMMARY/ABSTRACT
When functional impairments in later life overwhelm available caregiving, older persons and their caregivers
commonly consider if moving from home into an institution, such as a nursing home, assisted living facility or
residential care facility for the elderly, is best for them. Persons and caregivers hope clinicians will help them
decide, but evidence and frameworks that clinicians can use to provide guidance are largely absent. We could
improve how clinicians help patients and caregivers navigate this process through a decision aid, but an aid
first requires data on how person- and caregiver-centered measures change with institutionalization and a
better understanding of what information persons and caregivers want. The objective of this proposal is to
supply those data and that understanding through mixed methods. Aim 1 will produce the first nationally
representative descriptions of trajectories in function, caregiving, and adequacy of support (eg, did persons
bathe less than they wanted due to lack of help) in the year before and after institutionalization and examine if
trajectories meaningfully differ in pre-specified subgroups (eg, by age, race, or type of institution). Aim 2 will
explore the experience of recently institutionalized older persons and their caregivers to understand the role of
function, caregiving and inadequate support in their transition and what information (if any) was and would
have been useful. We integrate our methods by using results from Aim 1 to inform sampling and by presenting
findings from Aim 1 to interviewees in Aim 2; by exploring feedback to a concrete example, we will gain a
better understanding of what kinds of information are useful to persons navigating this transition. Together,
these aims will be the foundation for future work developing decision aids for the institutionalization process
and then implementing and evaluating them in randomized controlled trials.

Public health relevance
PROJECT NARRATIVE Older persons and caregivers hope clinicians will help them decide if institutionalization in a nursing home, assisted living facility or residential care facility for the elderly is right for them, but evidence and frameworks that clinicians can use to provide guidance are largely absent. To produce decision aids for this important and common transition, we need a better understanding of 1) how patient- and caregiver-centered outcomes like function, caregiving hours, and adequacy of support (eg, did persons bathe less than they wanted due to lack of help) change with institutionalization and 2) what information older persons and caregivers want as they navigate this difficult process. This training grant will produce data on these outcomes and explore the experience and information needs of recently institutionalized older persons and their caregivers and in doing so, will lay the foundation for future work developing, testing and implementing these decision aids, and position the candidate to become a leader in this field at the intersection of geriatrics, palliative care, and health care delivery models.